West African Emerging Infectious Disease Research Center (WA-EIDRC)

PROJECT SUMMARY
With the increasing use of oral antiviral treatments for acute SARS-CoV-2 infection, there
have been multiple reports of symptom and viral load rebound after the prescribed
treatment course. The most prescribed oral antiviral is Paxlovid, and while it has become a
component of test-to-treat programs, there are no incidence or prevalence numbers on
Paxlovid (symptomatologic and/or virologic) rebound after the ﬁve-day treatment course.
Further, the connection between symptoms, viral load rebound, and immune correlates is
unknown as well. This is of utmost urgence from a public health standpoint, given the
possibility of the individual remaining infectious despite Paxlovid treatment and concerns
about the potential development of drug resistance. Therefore, with additional funding we
propose to study the incidence, prevalence, symptomatology, virus evolution, and immune
correlates of COVID-19 cases who rebound after completion of Paxlovid treatment.

Public health relevance
PROJECT NARRATIVE As the COVID-19 pandemic ensues, the promise of ambulatory oral therapeutics has led to widespread use of Paxlovid. However, there have been signiﬁcant reports of symptomatologic and virologic rebound after the current approved ﬁve-day course. To understand the epidemiology and pathophysiology of Paxlovid rebound, we will perform additional testing including virus sequencing, systems serology, and symptomatology assessments in a large cohort of COVID-19 patients who qualify for Paxlovid.